Clinical Trial Concept in the Oncology Landscape

Project Summary
The Clinical Trial Concept in the Oncology Landscape (CTC) is a virtual and in-person, hybrid course
designed to educate oncology trainees and junior faculty from any cancer specialty in applying Good Clinical
Practice (GCP) and scientific reasoning into effective clinical trial design. The course will accept junior
oncologists and fellows/residents in an oncology specialty, who are novice in cancer clinical research. The
course will deliver in Part 1, The Fundamentals of Clinical Research, a semester long virtual immersive
educational experience across all areas of cancer clinical research, then culminate in an in-person Trial Concept
Writing Camp (Part 2) during the annual American Association of Cancer Institute (AACI) Clinical Research
Innovation (CRI) meeting where participants will be mentored by experienced clinical investigators from different
AACI member institutions during which time, they will finalize a clinical trial concept (also called letter of intent
(LOI)), the end product of this course. Participants are selected through a competitive application process
consisting of a CV, personal statement, letter of support from a local clinical research mentor, and a career
development plan. Accepted participants will first receive scientific and GCP training over 20 virtual sessions
covering the 6 major modules of protocol development that encompass the eleven domains of clinical trial
expertise, including oncology, science, medicine, business/negotiation, accounting, statistics, pharmacy,
pharmacology, laws and regulations, ethics, and clinical trial management. The curriculum will be loaded on a
web portal developed for educational purposes under another U24 NCI award to OSUCCC. The virtual training
will use a flipped classroom approach to maintain participant attentiveness. At the CRI meeting, participants will
interact with Faculty mentors, nationwide experts in clinical research, who will help them complete a realistic
concept form that meets scientific standards. Participants will take part in pre- and post-tests to determine the
cogency of the CTC curriculum for their professional practice, and the effectiveness of the course logistics. They
will complete the course by submitting a finalized clinical trial concept to the CTC course directors. Afterwards,
they should be able to use their concept to develop a full protocol at their own institutions or though the NCI
clinical research networks or other clinical trial networks. After the course, public data will be used to track
participants’ career trajectories to determine the long-term effects of the course on their careers, working with
Academics Analytics, a company contracted with OSU.
Impact. Investigators must apply GCP and the International Conference on Harmonisation (ICH) guidelines to
the design and scientific approach of their clinical research. The basics of clinical research are not taught in
medical schools or residencies. The pool of clinical investigators has also decreased in the US, creating a serious
shortage of clinical trial experts. At the same time, there has been an explosion of biological discoveries and
technological advances. This innovative and necessary CTC course will address the need for thorough and
specific training on clinical trial design and execution to eventually benefit patients with cancers and support the
professional development of junior oncology faculty.

Public health relevance
The "Clinical Trial Concept in the Oncology Landscape" course trains early-career investigators in oncology how to design a cancer clinical trial concept that is scientifically sound and feasible. The primary objective is to ensure that physician researchers have the tools they need to ethically, effectively, and scientifically design an interventional clinical research concept that can later be used to conduct clinical trial of new therapeutic treatments and approaches to cancer care.